HIV Viral Load Testing Using CRISPR Cascade Signal Amplification

Abstract
The HIV/AIDS epidemic poses a major threat to public health, affecting 40 million people worldwide. Early
diagnosis of acute HIV infection during the seroconversion window facilitates early intervention. Monitoring HIV
viral load frequently during antiretroviral treatment (ART) is essential to confirm treatment effectiveness and
detect viral rebound. HIV viral load testing, which quantifies HIV viral RNA (circulating virus) in plasma, is the
gold standard and the most effective method for ART monitoring and acute HIV detection. However, standard
HIV viral load testing methods rely on expensive equipment and well-trained personnel, limiting their use to
centralized laboratories and hospital environments. Although several portable HIV RNA diagnostic platforms are
commercially available, they still require relatively expensive (> $10K) benchtop instruments and trained
technicians, rendering them unsuitable for point-of-care applications. Here, we propose to develop a rapid,
affordable, and sensitive CRISPR cascade signal amplification approach for HIV viral load testing in clinical
samples. We will investigate the allosteric regulation mechanism of CRISPR activation by HIV RNA with various
secondary structures and sequences. Furthermore, we will develop a CRISPR cascade signal amplification
assay for HIV detection at room temperature. To simplify the detection operation, we will incorporate the assay
into a microfluidic platform to create an accessible diagnostic tool. We will validate the clinical application of this
microfluidic diagnostic approach in collaboration with clinicians. If successful, this simple and cost-effective
CRISPR cascade signal amplification method will enable acute HIV diagnosis and viral load testing at resource-
limited settings.

Public health relevance
Narrative To address the global health concern of HIV/AIDS epidemic, the rapid, simple and affordable HIV viral load testing is urgently needed. The project will develop a novel, highly sensitive and specific CRISPR cascade signal amplification approach for HIV viral load testing. We will rigorously evaluate its clinical performance in quantifying HIV RNA in clinical samples, enabling the clinical translation of a sensitive, personalized, HIV viral load testing.